Extension of NEURON simulator for simulation of reaction-diffusion in neurons

Development of simulation bioengineering techniques in medical neuroscience has been limited due to
computational neuroscience's focus on the higher capacities of humans, such as the ability to play
chess or go. That has led to the notion that the brain can best be understood by recourse to the
concepts of computer science: artificial neural networks, information theory, Bayesian inference,
pattern recognition, etc. Whether or not these tools are sufficient for understanding human
neocortical function, they are clearly not sufficient for understanding the nervous system
dysfunction seen in neurological and psychiatric pathology. Brain disease, like diseases of other
organ systems, is disease of biological tissue, and must eventually consider energetics and
oxygenation, blood and brain pressures, as well as chemical reactions and diffusion of toxins and
pharmaceuticals. Such full-organ simulation will require linkages to other simulators. Through such
linkages, as well as through internal extensions, we have been extending the widely-used NEURON
simulator to handle reaction-diffusion in neural tissue in order to better understand brain
signaling, neurodegenerative toxic cascades, and drug effects. For the current funding period we
will further augment NEURON's NRxD module through 4 Aims: 1. Improve synaptic modeling techniques
by considering presynaptic volume, cleft and postsynaptic volume together to handle ionotropic
synapses, metabotropic synapses, gap junctions and complex combination synapses; along with
reuptake, diffusion, electrodiffusion, neurotransmitters, second messengers and retrograde
neurotransmitters in a coordinated way. 2. Allow more rapid and more extensive exploration of
parameter space by improving simulation speed and by allowing full state variable saving for
improved simulation initialization and recovery from high-performance computing failures. 3.
Develop both Python-based and socket-based application programming interfaces (APIs) for easier
linkage with other simulators, including for electrodiffusion and for various types of stochastic
simulation. 4. Continue package dissemination and education in order to get more computational and
experimental NRxD users. We will continue to offer twice-yearly tutorials, and to sponsor
additional workshops at Computational Neuroscience and at other meetings. We will integrate online
tutorials with the documentation to provide both Programmer's Reference and Biological Reference
online manuals. We will develop a set of video tutorials associated with these that will eventually
be linked together to make an online course. Overall, we expect that our novel simulation
neurotechnology will be of increasing use and utilization both for research use, and for future
clinical adoption in personalized medicine.

Public health relevance
Narrative The enormous complexity of brain interactions makes understanding brain diseases such as stroke, autism, and Alzheimer disease extremely difficult. Part of this complexity lies in the need to understand how the chemicals that underlie learning and memory, and brain energy, interact with the electrical signals that travel along nerve fibers. We are extending NEURON, one of the most widely used nerve and brain computer simulators, to simulate chemical reactions both inside and outside of cells. This will allow us to better understand the roles of oxygen, toxins and drugs in brain dysfunctions of neurological and psychiatric disease.